Nitric Oxide, Oxygen and Mechanical Stress in Cartilage

DESCRIPTION (provided by applicant): Biomechanical factors, chondrocyte viability, and inflammation are important factors in the pathogenesis of arthritis. Nitric oxide (NO) synthesis is increased in arthritis and is a mediator in the response to mechanical compression, chondrocyte apoptosis and in the inflammatory response to the catabolic cytokine IL-1. The most direct effect of NO is the suppression of energy production, which in many cell types is then associated with decreased oxygen (02) consumption, decreased matrix synthesis and the control of cell death. NO and 02 competitively bind to cytochrome oxidase, which is involved in oxidative mitochondrial respiration (OXPHOS). However, articular chondrocytes are highly glycolytic due to their avascular and hence hypoxic environment and OXPHOS only accounts for up to 25% of total steady state ATP production. It is suggested OXPHOS may contribute to more ATP production under conditions of tissue stress, such as inflammation or mechanical stress, or in arthritis where the oxygen tension of the synovial fluid, and hence cartilage, is further decreased. A steady supply of ATP is essential for articular chondrocyte remodeling of the matrix as an adaptation to biomechanical or inflammatory stresses, but also for the high energy requirements of apoptosis. NO is suggested to have both a protective and destructive role in cartilage. Little is known concerning the effect of NO and oxygen on ATP production in articular cartilage under physiological or ipathological conditions. The putative protective effect of NO might be determined by the intracellular redox state since NO and 02 compete for binding to cytochrome oxidase of the mitochondria. Our primary hypothesis is that oxygen tension determines whether NO inhibits ATP production, and if sufficient ATP is available to respond to inflammatory or mechanical stress. We propose to test whether oxygen tension l affects the ability of NO to inhibit the aerobic OXPHOS pathway and hence the source of ATP required to respond to the inflammatory or mechanical stress. We then propose to investigate how these factors affect matrix turnover and cell death. Since mechanical stress is protective to IL-1 induced matrix breakdown we shall investigate if this phenomenon is influenced by oxygen tension.